NIH-DOD-VA Pain Management Collaboratory Coordinating Center

Project Summary / Abstract
The Pain Management Collaboratory Coordinating Center (PMC3) will continue to provide national
leadership for the NIH-DOD-VA Pain Management Collaboratory (PMC), building on its successes over the
original six-year period of funding. Three key aims are to: 1) develop, adapt, and adopt technical and policy
guidelines and best practices for the effective conduct of research in partnership with healthcare systems
focused on Veterans, military personnel, and their families; 2) work collaboratively with and provide technical,
design, and other support to Pragmatic Clinical Trial (PCT) teams, to develop and implement a pragmatic trial
protocol; and 3) disseminate widely Collaboratory-endorsed policies and best practices and lessons learned in
the PCTs for implementing research within healthcare settings. Continuation of the PMC3 will permit continued
support for the original eleven and two recently funded PCTs as well as PCTs to be funded via current and
future requests for proposals. The PMC3 will continue to leverage the infrastructure, experience, and expertise
thus far established by the Coordinating Center. Specifically, these aims will be accomplished through the
highly collaborative community that comprises the PMC Steering Committee and through PMC3-managed
Work Groups, a Patient Resource Group, and theme-based Discussion Groups. Essential to the continued
success of the PMC is its focus on developing and sustaining strong partnerships with military Veterans and
service members and with VA and DOD health care providers and organizational leaders. These partnerships
ensure the meaningfulness and relevance of the research for addressing significant gaps in the management
of pain and co-occurring conditions in these systems. These partnerships also help to ensure that positive PCT
results and products have a high likelihood for adoption in these systems, and potentially other health care
delivery systems. The proposed PMC3 continuation will support ongoing and future innovations and other
successes and yield significant and impactful technical policy guidelines, best practices, and lessons learned to
support the PMC and future PCTs.

Public health relevance
PROJECT NARRATIVE On behalf of the NIH-DOD-VA Pain Management Collaboratory (PMC), the Pain Management Collaboratory Coordinating Center (PMC3) will continue to provide national leadership and serve as a national resource for development and refinement of innovative tools, best practices, and other resources in the conduct of high impact pragmatic clinical trials (PCTs) on nonpharmacological approaches for pain management and other comorbid conditions in Veteran or military healthcare systems. In the next six-year continuation phase of the PMC, we will support the successful completion and widespread dissemination and implementation activities of the originally funded PCTs, support the successful enactment of new PCTs, and continue to generate new knowledge and resources in the service of improving the design and conduct of future PCTs.